Institutional Career Development Core

The overall vision of the Rockefeller University Center for Clinical and Translational Science (CCTS), supported
by the CTSA program, is to develop, demonstrate, and disseminate innovative programs so as to create a model
clinical research enterprise built on rigor, responsible and transparent reporting, and scientific integrity to
empower translation of paradigm-breaking discoveries into better human health. The overarching goal of our
KL2 Clinical Scholars Master's degree program is to prepare our trainees to be successful, scientifically
independent, translational investigators who can lead translational teams on projects to improve human health.
The core of the program is a mentored translational research experience in which the Scholar serves as a
translational team science leader, and develops, conducts, analyzes, and disseminates the results of a human
participant study under the guidance of a distinguished senior scientific mentor and with the assistance of a
cadre of Translational Science Team Experts/Educators. This experience is complemented by a didactic
curriculum including tutorials in Clinical and Translational Science, Biostatistics, Bioinformatics, and
Epidemiology; a weekly Clinical Research Seminar by outstanding translational investigators; a private weekly
meeting with the seminar speaker; team science leadership training; a graduate level scientific course;
Humanities and Translational Science special events; and training in the Responsible Conduct of Research. Our
program benefits from the scientific strength of the mentors in the program, with 10 of the mentors of Scholars
during the current grant period being elected members of the National Academy of Sciences. Thus, our specific
aims are: 1. To train physician scientists and doctoral level health professionals as outstanding, scientifically
independent translational investigators in a 3 year mentored KL2 Clinical Scholars Master's degree program that
includes: a) leadership of a human participant protocol from conception to reporting, b) a didactic curriculum to
help the Scholar master the competencies to function as a rigorous independent translational scientist, c)
focused instruction and feedback to develop the team science leadership competencies required to successfully
lead a translational science team. 2. To introduce new educational programs to maximize Scholars' educational
experience and ability to consider a wide variety of career choices, as well as benefit from emerging new
technology and resources: a) Team science leadership training, b) Pharmaceutical production and formulation,
d) Ontology-driven human phenotyping, e) Searching Electronics Health Records and causal inference, e) From
discovery to health-enhancing product, and f) Engaging communities as full partners. 3. Reinforce the
importance of achieving the highest possible levels of rigor, reproducibility, and reporting (R3) and assist
Scholars in developing best practices early in their research careers so that they can incorporate new methods
and policies to constantly improve their adherence to evolving standards.